Biochemical and biophysical elucidation of lanthanide sorting by proteins of the lanthanome

Project Summary
Recent efforts have established the first roles of lanthanide ions in biology. These ions, previously not
understood to have a biological role, have been shown to serve essential catalytic and functional purposes.
Particularly owing to increased use of lanthanide ions in health applications for imaging and therapeutics, the
discovery of biological function comes with a need to understand criteria governing the selection, transport, and
utilization of these ions. Unlike main-group and transition metal ions, whose selection and use in biology has
been much more thoroughly explored, lanthanide ions have comparatively similar properties to one another.
Therefore, understanding the mechanisms by which bacteria sort and transport lanthanides contributes to the
growing field of lanthanobiology, but can also add a new perspective to the general study of cellular metal ion
trafficking, an essential biological process.
I plan to address gaps in understanding of lanthanide recognition and uptake in bacteria through studies
aimed at the role of protein-lanthanide and protein-protein interactions in the trafficking of lanthanide ions. These
studies will contribute to a strengthened foundational understanding of protein-lanthanide interactions and the
contributions of these interactions to the selectivity of lanthanide ion transport in biological systems.
The proposed research will take place in the laboratory of Prof. Joseph A. Cotruvo, Jr. at Pennsylvania
State University (Penn State). The high level of collaborative research in bioinorganic chemistry at Penn State
will afford access to both broad technical knowledge in the study of biological metals and career mentorship in
the field. Additionally, I have found many opportunities for continued training in teaching and research mentorship
in line with my goal of doing research at a primarily undergraduate institution. Along with Prof. Cotruvo’s expertise
in the discovery and characterization of lanthanide-binding proteins, these resources and the proposed research
will expand my knowledge of and prepare me for a career in bioinorganic chemistry in addition to advancing
understanding of lanthanide ions’ role in biology.

Public health relevance
Project Narrative Uptake, recognition, and trafficking of metal ions are fundamental cellular processes, and understanding these mechanisms in bacteria illuminates the ways in which cells may respond to nutritional stress. Lanthanide ions are increasingly used in medical imaging and therapeutics alongside other technologies, but native biological systems which use them have only recently been discovered and the mechanisms underlying recognition and transport of lanthanide ions in cells are therefore relatively unknown. In the proposed study, I will characterize aspects of a bacterial lanthanide uptake pathway with the goal of contributing towards a more complete understanding of bacterial metal ion transport.